The Role of Highly inflamed Epicardial Adipose Tissue in the Development of Atrial Fibrillation

Project Abstract
My long-term goal is to be a clinical-translational research scientist focused on developing effective therapies
for patients with cardiovascular disease. My background in the development and physiology of adipose tissue
as well as clinical training in cardiovascular medicine have motivated me to better understand the molecular
mechanisms by which epicardial adipocytes influence the development of atrial fibrillation. I proposed to
conduct a prospective clinical investigation to test the hypothesis that adipocytes are recruiting myeloid cells to
the myocardium to increase vulnerability for postoperative AF. The specific aims of the parent K23 proposal
are:
Aim 1. Characterize transcriptomic profiles of epicardial adipocytes and determine circulating levels of
adipose-derived chemokines
Aim 2. Determine the relationship between inflammation in epicardial adipose tissue and left atrial function as
assessed by echocardiographic parameters, including left atrial volume index, left atrial function index and left
atrial mechanical dispersion.
Aim 3. Examine the relationship between inflammation in epicardial adipose tissue and incident postoperative
AF after coronary artery bypass graft surgery
I am seeking an administrative supplement to the parent K23 award to provide bioinformatic support for
analyzing single nuclei RNA sequencing and proteomics datasets to better understand the molecular
mediators of inflammation and identify new treatments for postoperative AF.

Public health relevance
Public Health Relevance: Atrial fibrillation (AF) occurs in 30-50% of patients undergoing cardiac surgery and is associated with prolonged hospital stay, hemodynamic instability, increased risk of stroke, and increased mortality. I observe significant associations between epicardial adipose tissue, inflammation and AF. This study will explore the molecular mechanisms underlying these associations to identify new targets for the development of effective treatment for postoperative AF.